Sex-Specific Psychosis Biotypes: Informed Data-driven Neurobiological and Genomic Markers for Early Risk Detection

Project Summary
This proposal aims to address the lack of sex-specific research in psychosis, which hinders the development
of sex-informed risk detection and tailored interventions that hold strong promise to improve the outcome of
psychotic disorders (PDs) and reduce their substantial clinical and economical burden. However, the current
diagnostic systems primarily rely on specific symptoms that may not yet be present in the prodromal stage, and
do not consider sex differences. This has motivated a shift towards neurobiological and genetic markers that are
known to show recognizable psychosis-related abnormalities, predisposition, and sex differences around early
adolescence. First we propose to develop a novel two-mode unsupervised and supervised data-driven approach
to decipher biological heterogeneity based on the brain’s functional connectivity (FC). The new approach will be
applied to a large transdiagnostic B-SNIP cohort of 1200+ individuals with PD to identify subgroups in these
individuals, such that these subgroups show distinct neurobiology and differential sex prevalences, denoted as
sex-specific biotypes. This will provide a more comprehensive and accurate understanding of the characteristic
pathophysiological brain changes in each PD subgroup, in a sex-informed manner. We will connect these
characteristic pathophysiological FC changes to behavioral and cognitive measures to better understand their
clinical manifestations. In addition, we will also develop a biologically-informed multivariate data fusion approach
to identify genomic factors related to the pathophysiological FC changes that characterize individual PD biotypes.
Particularly, we will identify both sex-differential and sex-interacting geomic-FC factors . This will improve our
understanding of the sex-stratified genetic predisposition for FC alterations of individual PD biotypes. These
genomic factors and PD-related FC alterations will be utilized to develop a sex-informed biotype detection
toolUsing B-SNIP and our unique uncharted longitudinal dataset of 220 adolescents with first-episode psychosis.
We will then test and validate this detection tool for early risk prediction using the longitudinal NAPLS-3 dataset
that includes ~690 clinical high-risk individuals, and the large longitudinal ABCD cohort of 11000+ adolescents
recruited at age of 10 years old, and follow-up till young adulthood. The validated biotype detection tool will be
made publicly available to the research community via GitHub to facilitate early risk detection and developing
tailored prevention and intervention strategies.

Public health relevance
Project Narrative This proposal will address the lack of sex-specific research in psychosis by developing a novel two-mode unsupervised and supervised data-driven approach. We will apply this approach and our new biologically- informed data fusion technique to the B-SNIP dataset of 2300+ individuals to identify sex-specific and sex- common biotypes and their neurobiological and genomic biomarkers. A sex-informed biotype detection tool will be developed and evaluated using our unique longitudinal dataset of adolescents with first-episode psychosis, the largest dataset of clinical high risk subjects in North America, and the longitudinal ABCD dataset with over 11,000 adolescents, enabling the identification of high-risk individuals across different age ranges.